Controlling Locomotion over Continuously Varying Activities for Agile Powered Prosthetic Legs

PROJECT ABSTRACT
The overall goal of this project is to model human joint biomechanics over continuously-varying locomotion to
enable adaptive control of powered above-knee prostheses. Above-knee amputees often struggle to perform the
varying activities of daily life with conventional prostheses due to the lack of positive mechanical work and active
control. Emerging powered prostheses have motors that can perform these missing functions, but the
biomechanics experienced by the user depend on the control of these motors. The way the prosthesis interacts
with both the user and environment can be controlled through joint impedance—the relationship between joint
motion and torque. Prosthetic joint impedance is typically defined via a stiffness, viscosity, and equilibrium angle
for discrete phases of gait within a limited set of discrete activities, but this framework does not allow continuous
variations of steady-state activities (e.g., walking at different speeds/inclines) or continuous transitions between
activities (e.g., walk to stair ascent). The central hypothesis of this project is that variable joint impedance can
be parameterized by a continuous model based on measurable quantities called phase and task variables. This
project will use machine learning to identify variable impedance functions from able-bodied data including joint
perturbation responses across the phase/task space to bias the solution toward biological values. The resulting
impedance model will be used with real-time estimates of phase and task variables to control a custom powered
knee-ankle prosthesis and the Össur PowerKnee across activities. The specific aims are as follows:
Aim 1: Model and control joint impedance over continuums of steady-state activities.
Hypothesis: We hypothesize that knee and ankle impedance during walking and stair climbing can be modeled
and controlled as continuous functions of gait phase, speed, and terrain inclination.
Aim 2: Model and control joint impedance over continuous transitions between activities.
Hypothesis: We hypothesize that knee and ankle impedance during continuous transitions between sitting,
standing, walking, and stair climbing can be modeled and controlled as functions of transitional task variables.
Aim 3: Implement continuous impedance controller and clinician interface on commercial hardware.
Hypothesis: The impedance control system implemented on the Össur PowerKnee with a partially-automated
tuning process will improve amputee endurance and symmetry over activities of daily life.
This project will be scientifically significant to understanding how human joint mechanics continuously
adapt to varying tasks and terrains, technologically significant to designing agile, biomimetic powered prosthetic
legs for community ambulation, and clinically significant to the widespread adoption of intuitive powered
prostheses for improved patient outcomes. The adaptability and clinical viability of this control paradigm will
have a profound impact on mobility and quality of life for nearly a million Americans with lower-limb loss.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the clinical application of variable-activity powered prosthetic legs can significantly improve community mobility and therefore quality of life for nearly a million Americans with lower-limb loss. Emerging powered prostheses are limited to a small set of pre-defined activities, which does not allow continuous variations of steady-state activities (e.g., walking at different speeds/inclines) or continuous transitions between activities (e.g., walking to stair ascent). This project will model and control joint biomechanics over continuously-varying activities for the design of agile, powered prostheses that require little to no tuning, which aligns with the missions of the Devices and Technology Development program area of the NICHD National Center for Medical Rehabilitation Research.